Personalized Cystic Fibrosis Therapy and Research Center

PROJECT SUMMARY: The “Pilot and Feasibility Program” will foster the development of new and early
stage investigators and to provide seed-support for innovative and cutting edge projects to rapidly advance
the scientific and research interests of the Personalized Cystic Fibrosis Therapy and Research Center
(PCFC).
This program is designed to support highly innovative research relevant to personalized CF
medicine and to facilitate the transition of new and early stage investigators to obtain extramural funding
and to sustain their individual research program. We have several new and early stage investigators at
CCHMC who are passionate in personalized CF medicine research. They currently do not have NIH RO1
funding, but have other types of funding such as NIH K-type award and RO3 award, support from private
foundations (i.e., Parker B Francis, CFF, American Heart Association (AHA), Cincinnati Children’s Research
Foundation (CCRF), to name a few). In addition, we will also encourage established investigators who wish
to extend their research program into personalized CF medicine research. It is the intention of the PCFC to
encourage these investigators to develop an innovative research program that would blaze new trails in the
area of CF/CFTR related basic research and develop translational program with personalized CF medicine
theme.